ENDOTHELIUM AS AN ACTIVE FUNCTIONAL BARRIER IN TISSUES

To understand the hormonal regulation of saliva production, it is necessary to investigate how these chemical mediators cross the endothelial barrier from the systemic circulation. As a probe to study such an event, capillary endothelial cells have been isolated and established into a stable cell line. These cells grow in a relatively simple media, form specialized intercellular connections and eventually generate macroscopic capillry-like structures. The ready availability of such cells, capable of capillary formation in vitro in the absence of added factors, constitute a simplification for cell biological and biochemical studies and provide a model system where capillary proliferation is thought to play a central role in pathophysiology.